The Unfolded Protein Response in Ischemic Stroke

Abstract
Ischemic stroke is a leading cause of death and long-term disability worldwide, and other than reperfusion
therapy, almost no treatment is available. Thus, there is an urgent need for new stroke therapies, particularly
those that demonstrate efficacy in the elderly, when most strokes occur. Mounting evidence indicates that
proteostasis-based therapeutics have great potential in treating aging- and/or ischemia-related diseases that are
characterized by a disrupted proteome. Especially, the unfolded protein response (UPR), which comprises
multiple adaptive response pathways that facilitate recovery of proteostasis, has been increasingly recognized
as a highly promising therapeutic target for neurodegenerative and ischemic diseases. The UPR is activated
when the proteome in the endoplasmic reticulum (ER), a key organelle for protein folding and maturation, is
perturbed, a condition called ER stress. The primary purpose of the UPR is to restore cellular proteostasis and
promote cell survival. The UPR has 3 major branches, named after 3 ER stress sensor proteins: ATF6 (activating
transcription factor 6), IRE1(inositol-requiring enzyme 1), and PERK (protein kinase RNA-like ER kinase). It is
well known that ischemic stroke causes ER stress and activates the UPR. Importantly, our extensive data have
established that activation of the UPR in neurons during the acute stroke phase is neuroprotective, strongly
endorsing the therapeutic potential of the UPR in ischemic stroke. But, to develop safe and effective UPR-based
pharmacologic interventions in stroke, we must further know 1) how the UPR affects other brain cell types,
especially astrocytes – the most abundant cell subtype in the brain, and 2) how UPR modulation impacts long-
term stroke outcome. Thus, the objectives of this renewal proposal are to determine the astrocytic role of the
individual UPR branches in stroke pathophysiology, and to assess the therapeutic potential of targeting the UPR
in stroke using young and aged animals. Our overarching hypothesis is that the individual UPR branches
influence stroke outcome in a cell- and phase-specific manner and thus, must be harnessed accordingly for
optimal UPR-based therapeutic strategies in stroke. Guided by our preliminary data, and also inspired by exciting
advances in the field, we will pursue 3 specific aims: 1) Determine the role of the ATF6 UPR branch in ischemic
stroke; 2) Determine the role of the IRE1/XBP1 UPR branch in ischemic stroke; 3) Determine the role of the
PERK UPR branch in ischemic stroke. The proposed research is significant because we expect to clarify the role
of each astrocytic UPR branch in stroke, and to determine the effects of pharmacologic modulation of the UPR
on stroke outcome in the context of stroke phase and aging. Such knowledge will be fundamental to informing
the development of new UPR-based strategies aimed to improve quality of life for stroke patients.

Public health relevance
The proposed research is relevant to public health because this project will investigate the role of endoplasmic reticulum stress response in stroke. This is relevant to the NIH’s mission because the knowledge obtained from the proposed research will be the basis for potential new therapeutic strategies to improve neurologic function of stroke patients, which will advance the Nation’s capacity to protect and improve health.